ROLE OF C-MYB IN T-LYMPHOCYTES PROLIFERATION

Our recent experiments demonstrated that the human c-myb gene plays a critical role in the control of the proliferation of hematopoietic cells of both myeloid and lymphoid lineages. However, the precise mechanism(s) by which c-myb regulates cell proliferation remains unknown. Our present goal is to elucidate the functional role of c-myb in T lymphocyte proliferation by determining whether genes directly involve in DNA synthesis are down regulated by inhibition of c-myb protein synthesis, if the promoters of these genes are directly or indirectly regulated by c-myb and to identify other genes that might be directly regulated by the c-myb protein. These studies should enable us to determine at which level and by which mechanism(s) the human c-myb gene controls cell proliferation in T lymphocytes.